New Transformation Technology for Gene Editing of Human Mitochondrial DNA Associated With Mitochondrial Diseases

PROJECT SUMMARY
Human mitochondrial DNA (mtDNA) encodes 37 genes in a small genome of 16,569 bp, which
accounts for 0.005% of the total human genome size. Despite the small size of this genetic
information, mtDNA is indispensable to human cells. As mitochondria are critical for cellular
respiration and ATP production, mitochondria are often referred to as “the Powerhouses of the
cell”. Because of their importance, mutations in mtDNA can cause severe diseases and
disorders in humans. These include but are not limited to muscular/neurodegenerative and
developmental disorders such as Kearns-Sayre syndrome (KSS), Leber’s Hereditary Optic
Neuropathy (LHON) and MELAS disorders. Mutations in mtDNA are also suggested to
correlate with a predisposition for common diseases like diabetes, Alzheimer’s disease,
Parkinson’s disease and even aging. Although the causal relationships between certain
mutations in mtDNA and their corresponding diseases were reported decades ago, cures have
not been realized due to the difficulty in accessing the sub-cellular structures in vivo. Also,
CRISPR technology has not been applicable to mitochondria until recently and corresponding
gene therapy of mtDNA still remains challenging in humans.
The major challenge of mitochondrial gene editing is the lack of DNA transformation approaches
for human mitochondria. No selectable marker gene has been developed that enables
mitochondrial transformation in human cells. As part of our efforts for mitochondrial
transformation in crop plants, we have used a novel selectable marker gene to develop a
method that has shown good efficacy in rice and yeast. In this proposed project, we will apply
this method to human mitochondria. A successful demonstration will be a major advancement
for the application of our organelle gene editing technology to human mitochondrial DNA, which
will facilitate future gene therapy treatments for the repair of mtDNA mutations in patients
suffering from severe mitochondrial diseases.

Public health relevance
Project Narrative Using our proprietary CRISPR organelle gene editing and transformation technologies, we aim to enable correction of human mitochondrial DNA mutations, which are the causes of a number of severe human genetic diseases and also predispose for Parkinson’s and Alzheimer’s diseases as well as the aging process. This first-phase project will apply our novel selection method to the transformation of human mitochondrial DNA, thereby providing a highly desired research technology to the scientific community. This advance will open new opportunities both in developing mitochondrial gene therapy and also in advancing basic research of mitochondria, the powerhouses of cells.